EOI:: IMPLEMENTING THE PRESIDENT'S "DEPARTMENT OF GOVERNMENT EFFICIENCY" COST EFFICIENCY INITIATIVE (MARCH 19, 2025):: EOI PARTIAL TERMINATION FOR CONVENIENCE AGREEMENT FOR SOLUTION DELIVERY MANAGEME

Under this contract, the contractor will independently provide solution delivery management, project management, program management, and project coordination services to satisfy the overall operational objectives of the National Heart, Lung and Blood Institute.